Health Promotion and Disease Prevention Research Centers: 2024 Special Interest Project Competitive Supplements (SIPS)-South Carolina Cancer Prevention and Control Research Network IV

PROJECT SUMMARY/ABSTRACT
Cancer-related health disparities in South Carolina (SC) are among the largest in the nation. The South
Carolina Cancer Prevention and Control Research Network (SC-CPCRN) is currently one of nine Centers for
Disease Control and Prevention (CDC) and National Cancer Institute (NCI)-funded Collaborating Centers
working to reduce cancer-related health disparities among disenfranchised and medically underserved
populations by advancing dissemination and implementation (D&I) science. In strong partnership with the
South Carolina Cancer Alliance; federally qualified health centers; and other academic, clinical, community,
and faith-based partners, the SC-CPCRN uses evidence-based approaches for the D&I of efficacious cancer
prevention and control messages, guidelines, and interventions. The relevance of our D&I efforts in SC is
strengthened considerably through established partnerships with our target audiences and stakeholders in
both urban and rural regions, leading to improved health outcomes. Our team’s well-recognized community-
engaged research approach to D&I science and community-clinical linkages increase the validity and
relevance of our work, ultimately providing all stakeholders with valuable information about strategies and
programming for improving health and reducing cancer-related health disparities. This work is guided by the
latest D&I science and national cancer research priorities. These priorities include (1) Healthy People 2030
objectives to increase cancer screening rates, decrease mortality, and increase survival; (2) National Center
for Chronic Disease Prevention and Health Promotion’s approach to the social determinants of health;
(3) NCI’s emphasis on rural cancer control; and (4) Blue Ribbon Panel recommendations of the Cancer
Moonshot focused on “expanding development and implementation of evidence-based interventions to reduce
cancer risk and cancer-related disparities”. We will utilize existing local and regional organizational
infrastructure and strong partnerships and will continue to encourage new linkages between community and
clinical partners for our center-specific and cross-center D&I initiatives. Our Specific Aims are to:
1) Disseminate, implement, and evaluate efficacious, multi-level, and multi-site public health, cancer control
interventions to address cancer-related health disparities; 2) Engage community and clinical partners in
research, training, and technical assistance to strengthen D&I science for cancer control in SC and nationally,
and translate effective community-based interventions for cancer prevention and screening into practice; and,
3) Increase the capacity of community and clinical partners in the D&I of evidence-based cancer control
strategies for reaching underserved, minority, and rural populations.

Public health relevance
PROJECT NARRATIVE Cancer-related health disparities in South Carolina are among the largest in the nation. The South Carolina Cancer Prevention and Control Research Network (SC-CPCRN) is applying for continued involvement as a CPCRN Collaborating Center that will allow us to draw on the extensive expertise of University of South Carolina-based faculty and staff committed to reducing these disparities by advancing dissemination and implementation (D&I) science through our well-recognized and established community-engaged research approach. We intend to engage the community, clinical partners, and other stakeholders in research, training, and technical assistance in order to increase the cancer prevention and control evidence base in South Carolina, build a workforce capable of effective D&I for cancer prevention and control strategies, and translate effective multi-level, community-clinical interventions into practice both in our state and nationally.